Role of the Retrosplenial Cortex in the Progression of AD Pathogenesis in Mouse and Human

PROJECT SUMMARY
While recent immunotherapies for Alzheimer’s disease (AD) have shown promise, they come with significant
side effects and may not work equally well for patients at different stages of AD. This necessitates a continued
focus on the development of AD therapeutics, especially on identifying the earliest drivers of AD. First, it is critical
that we know where in the brain to find the earliest events that contribute to AD pathogenesis. Evidence from
human literature indicates that the default mode network, in particular the retrosplenial cortex/posterior cingulate
gyrus (RSC/PCC)/precuneus regions, shows early amyloid deposition with concomitant elevations in metabolism,
though the functional implications of this observation are unknown. Anecdotal evidence also suggests that spatial
navigation may be amongst the earliest impairments observed in preclinical AD, which is consistent with
dysfunction of RSC. These findings all point to a potentially important role of the RSC in AD pathogenesis, yet
what is occurring in the RSC, when it occurs, and how it may contribute to AD-related disease has not been
explored.
In this proposal, we will define how neuronal hyperexcitability in the RSC contributes to the development of AD-
related behavioral deficits in mice, and the molecular mechanisms that underlie this effect. Our pilot data provide
strong support for a causative role of hyperexcitability in RSC layer 5 cells in the disease-associated loss of
memory in mice, as silencing RSC layer 5 cells prevented the age-associated loss of memory recall in AD model
mice. In this application, we will first define the effect of inhibition of RSC layer 5 cells on hippocampus-associated
spatial memory and spatial navigation tasks, and test when hyperexcitability emerges in these cells in Aim 1.
This will be done in 3 different mouse models, including amyloid and tau models. In Aim 2 we will explore the
transcriptional changes that occur in the RSC during disease progression in three different mouse AD models.
In Aim 3, we will assess the transcriptional changes that occur in the human RSC using human postmortem
samples from control, mild cognitive impairment, and AD patients. We will focus on identification of conserved
gene expression modules that change during the development of AD in the mouse and human brain, validating
our results using spatial transcriptomics and immunohistochemical validation. This study will provide support for
a critical role that RSC hyperexcitability plays in AD progression, and a mechanistic framework for how changes
in intrinsic excitability and synaptic function contribute to the development of AD.

Public health relevance
PROJECT NARRATIVE Though the retrosplenial cortex (RSC) exhibits elevated metabolism and amyloid deposition very early in human AD, their contributions for the progression of AD are not clear. In this application, we will test the functional consequences of preventing RSC hyperexcitability for the development of AD-related memory deficits and define the molecular changes that drive these phenotypes in both mouse and human. These experiments will detail a previously unappreciated role of the RSC in driving early AD pathogenesis and provide potential drug targets to slow AD progression.